Scrubbing Complex Sound Sources for Factory Situational Awareness

According to the CDC NIOSH website “Occupational hearing loss is one of the most common
work-related illnesses in the United States.” This is due, in part, to the number of workers
exposed to hazardous noise levels in the workplace who don’t use hearing protection devices
(HPDs). A National Health Institute Survey estimated that over 22 million U.S. workers are
exposed to hazardous noise levels at work annually. Another survey indicated over half of those
workers reported non-use of HPDs. Non-use of HPDs on factory floors is often not due to the
cost of such devices or lack of availability. In many cases, ear plugs and other HPDs can be seen
hanging around a worker’s neck or stuffed in a pocket! The problem is that, in addition to
blocking hazardous sounds, HPDs also block all other sounds in the environment but awareness
of alarms is critical for physical safety and job performance in these industries. We propose a
novel hearing protection system that provides enhanced access to “situational” sounds such
as alarms, forklifts, and voices, while simultaneously suppressing hazardously loud noises. By
overcoming the situational-awareness obstacle, we believe workers will be more willing to wear
HPDs that include our system.
Our solution uses innovative signal processing technologies to “scrub” hazardously loud
machines, each of which has been “tagged” by adjacent microphones (mics), from the response
mixtures of other, “situational” mics placed in more acoustically diverse locations in the
workspace. This scrubbing process removes the tagged noises from the response signals of the
situational mics, thereby enhancing the audibility of the other important sounds in the
environment. Unlike existing products, this scrubbing is independent of the frequency or
amplitude of the signal being scrubbed.
Based on successful results scrubbing noise from small sources, this project focuses on two
limitations of our current system: 1) Acoustic sensors used as tagging mics pick up situational
sounds in addition to the unwanted noise. This tagger contamination makes it more difficult to
scrub just unwanted noise from situational mics. We propose to investigate alternative sensor
technologies to reduce contamination. 2) Noisy machines typically have multiple underlying
noise sources (e.g. motors, pulleys, bearings) and relatively large shells encasing the noise
sources. Successful scrubbing requires as many tagging mics as distinct noise sources. We
propose to develop and test a procedure to identify the number and location of tagging mics
needed to scrub a machine with multiple internal sources.

Public health relevance
Narrative: Factory Noise Removal to Preserve Situational Awareness Hearing loss is one of the most prevalent occupation-related injuries. We will develop an advanced audio-processing system for high-noise workplace environments to deliver enhanced situational sounds of the worker's environment by removing the hazardously loud noises and presenting via common wiﬁ-enabled hearing protection. This will enable workers to hear both voices and important sounds such as alarms and backing forklifts, while still protecting their hearing.